Testing Strategies for Couple Engagement in PMTCT and Family Health in Kenya

Despite the potential for antiretroviral therapy to improve maternal health and reduce mother-to-child
transmission of HIV to as low as 1%, HIV-related maternal deaths and HIV infection among infants remain
unacceptably high across sub-Saharan Africa. This is particularly true in Kenya, where crucial drop-offs occur
in the cascade of prevention of mother-to-child transmission (PMTCT) services. Weak health systems
contribute to insufficient service coverage, but many barriers lie beyond the clinic—in the partner, family, and
community factors that shape women's health decisions. Our team's research in a high HIV prevalence area of
southwestern Kenya has shown that many women avoid couples HIV testing and do not adhere to PMTCT
regimens because they fear negative consequences from a male partner. Men can play a crucial supportive
role for family health, but male partners in Kenya are poorly engaged in antenatal care and uptake of couples
HIV testing during pregnancy is low. Pregnant women desire to be tested for HIV together with their partner
and need the support for mutual disclosure involved in couples HIV testing and counseling (CHTC), regardless
of whether they know their own HIV status. In this context, we propose to test the efficacy of an
interdependence theory-based couples intervention that reaches pregnant women and male partners through
home visits by male-female pairs of lay health workers, and includes offer of home-based CHTC services. Our
randomized pilot study of this intervention with 96 pregnant couples (R34MH102103) demonstrated significant
increases in uptake of couples testing (64% in intervention vs. 23% in control, p<0.001) and significant
improvements in health behaviors such as exclusive breastfeeding and postpartum care. We now propose a
more robust investigation to determine whether this intervention improves uptake of couples HIV testing and
health outcomes over and above less intensive male engagement strategies being used in the region. We
propose to conduct a three-arm trial among 1080 pregnant women and partners, randomizing them to home-
based couple visits, HIV self-test (HIVST) kits to use with their male partner, or standard care (male partner
clinic invitation letters), following couples up to 18 months postpartum. In Aim 1, we will determine the effects
of the intervention on our primary outcome of couple HIV testing, compared to HIVST kits and standard care.
In Aim 2, we examine intervention impact on HIV prevention behaviors, facility delivery, and postnatal
healthcare utilization. Among couples living with HIV, secondary outcomes include maternal VL suppression
and HIV-free child survival up to 18 months. In Aim 3, we compare the cost-effectiveness of the home-based
couples intervention to the less resource-intensive strategies used in the other two study arms. Our theory-
based couples intervention has strong potential to increase couple HIV testing and collaboration for family
health. This study will inform decision-makers about cost-effective strategies to engage pregnant couples in
PMTCT and family health, with important downstream benefits for maternal, paternal, and infant health.

Public health relevance
Project Narrative This research will contribute to public health efforts to improve the health of pregnant women, their male partners, and infants in low-resource settings by examining the efficacy and cost-effectiveness of a home- based intervention to increase couple HIV testing and counseling and mutual disclosure. Such efforts to engage both members of the couple in support of family health will have important implications for uptake of HIV prevention and treatment, as well as for maternal, paternal, and child health. This research has the potential to make important contributions towards reducing some of the most significant public health problems in sub-Saharan Africa, including mother-to-child transmission of HIV; maternal, paternal, and infant mortality; and transmission of HIV in serodiscordant couples.